COBRE in Vascular Biology

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To enhance data analysis capacity of small animal imaging core facility by providing full-time employment for data analyst and enhancing the computational power for large data file throughput.